Neural circuits underlying visual representation in the medial entorhonal cortex

SUMMARY
The ability of an animal to successfully navigate the world and carry out goal-directed behavior is
dependent on the hippocampus and entorhinal cortex but is also strongly shaped by visual information derived
from external cues. Indeed, manipulation or elimination of visual input can significantly disrupt ongoing activity
in these regions and impair tasks that require accurate internal representations of the local environment.
Considerable anatomical data indicate that the occipital cortex, including primary and higher-order visual areas,
sends projections to the medial entorhinal cortex (MEC). However, the ability of MEC neurons to encode visual
cues and the specific circuits mediating this function are largely unknown. Whether the MEC can respond to
low-level visual features or primarily represents complex, behaviorally salient relationships between stimuli has
not been examined. Furthermore, how visual inputs interact with ongoing network activity within the MEC is
unclear. In the present study, we propose a combination of electrophysiology, anatomical tracing, optogenetic
manipulation, and ex vivo synaptic physiology to (1) determine the capacity for visual stimulus representation
by MEC neurons, (2) identify the afferent pathways and specific subpopulations of MEC neurons that encode
visual input, (3) determine the microcircuit organization of connections within the MEC that shape visual
responses, and (4) link visually-evoked MEC activity to virtual navigation for reward. Our overall goal is to
understand the pathways by which visual information guides complex behaviors such as navigation through the
environment. We expect that our results will generate new avenues for exploring both the cellular and circuit
foundations of visual behavior and the mechanisms underlying coordination of activity between different brain
regions.

Public health relevance
NARRATIVE This proposal seeks to understand the cellular and circuit mechanisms underlying the representation of visual information by the medial entorhinal cortex (MEC), the gateway for sensory information to the hippocampus. We combine an array of electrophysiology, anatomical tracing, and optogenetic manipulation to monitor and manipulate neural circuits both in vivo and in reduced brain slice preparations. Results from these studies will identify the functional organization of connections between the neocortex and the MEC that underlie the the role of visual information in supporting navigation and spatial memory.